Core C - Data Core

Mount Sinai ADRC (Sano): Data Core (Core C) – Research Summary
An effective Data Management and Statistical Core (Data Core) facilitates strong connections across all
Cores within the ADRC, serves as a critical resource for ongoing Center activities and for other
investigators who are interested in research in Alzheimer’s disease (AD) and AD-related dementias
(ADRD), and helps accelerate research and translation in the field. Specifically, our Data Core will
provide a data and analytic foundation for Mount Sinai ADRC to explore the relationships between
multi-model data types to uncover unique pathways to diagnosis, treatment, and prevention of
AD/ADRD. We will build on our newly modernized and standardized electronic data capture (EDC)
enabled REDCap database structure that has curated, linked and integrated data across all cores. We
will enable new data types including polygenic risk scores (PRS), fluid and imaging biomarkers,
recorded speech for natural language processing (NLP), and digital neuropathological profiles
associated with vulnerability or resistance to disease in AD/ADRD. The Data Core will provide expert
statistical services and training on a variety of topics including study design, data harmonization and
integration, and advanced statistical methods within our Center, especially through the Research
Education Component (REC) core. The Data Core will continue to strengthen our productive Center-
NACC, Center-Center, and Center-NIH partnerships, building on our success with new publications,
grant proposals, and training opportunities. We will initiate new efforts in facilitating connection of AI
and AD/ADRD researchers to develop new partnerships. Our Specific Aims are (1) Provide a reliable,
quality assured, and secure multi-modal data and analytic infrastructure; (2) Provide integrated data
and statistical analysis and support; (3) Educate ADRC investigators, trainees, and junior faculty; and
(4) Broaden our impact by increasing Findability, Accessibility, Interoperability and Reusability (FAIR) of
our data. These activities are well aligned with priorities highlighted in the RFA. Throughout all Data
Core activities, we will continue to build a culture of innovation through the application of novel data
methods and encouraging open science through data sharing. We also aim to ensure diverse
perspectives of our faculty who are from multiple scientific disciplines and backgrounds and also
engage and serve our participants who have a wide range of diverse backgrounds.